HEAD AND NECK CANCER PATIENTS AND RADIATION THERAPY

Assess the energy expenditure and nutritional status of patients with head and neck cancer prior to radiation therapy and during treatment so that appropriate dietary supplementations can be made.